TRIAL TO ACCESS SAFETY/IMMUNOGENICITY/PROTECTIVE EFFICACY OF INFLUENZA VACCINE

To assess the safety, tolerability, immunogenicity and efficacy of the CAIV-T vaccine to protect childen receiving either a one-or two-dose primary vaccination against culture-confirmed influenza illness caused by subtypes antigenically similar to those contained in the vaccine or placebo (whether the subject received a one-or-two-dose primary vaccination regimen) and the end of the subsequent influenza season.